Neural mechanisms of host-microbiota interaction in hypertension: a potential for bio-electronic medicine

Abstract
Hypertension (HTN) is a prevalent cardiovascular condition and a leading risk factor for other cardiovascular
diseases. If it remains untreated, HTN can lead to numerous comorbidities such as stroke, dementia, diabetes,
kidney disease, obstructive sleep apnea, and neurological disorders. Despite advances in prevention and multi-
drug therapy, a significant proportion of patients remain resistant or refractory to current treatments. In most
cases, treatment-resistant HTN is strongly neurogenic, characterized by a dysfunctional autonomic nervous
system (ANS) most recently linked to gut dysbiosis. However, mechanisms of host-microbiota interaction in HTN
are not well defined. Our new preliminary data suggests that a breakdown in the neural gut-brain communication
resulting from gut dysbiosis may be mediated by reduced serotonergic receptor signaling on the vagal afferent
projections from the gut to the nucleus of the solitary tract. In this application, we propose to use state of the art
in vivo imaging, electrophysiology and neural stimulation approaches in transgenic and humanized rats in order
to interrogate specific molecular and neural mechanisms of host-microbiota interaction in health and HTN, while
evaluating the potential of sub-diaphragmatic vagal stimulation for bio-electronic medicine to alleviate the
symptoms of gut dysbiosis in HTN.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will identify distinct molecular and neural mechanisms underlying dysfunction in the host-microbiota interaction that results from gut dysbiosis in human and rodent hypertension. Moreover, this project will evaluate the potential for sub-diaphragmatic vagal stimulation as bio-electronic medicine approach for alleviating the symptoms of gut dysbiosis in hypertension. This would represent a significant advancement in our understanding of host-microbiota interactions in health and disease, and has a potential for an immediate and significant impact in treatment of hypertension.